Automated Ultra-Long DNA and RNA Extraction for Long-read Sequencing Applications

Summary
Claremont BioSolutions, LLC (CBIO)
The ability to sequence and map long stretches of DNA and RNA using third generation sequencing
technologies is set to transform the field of genomics and allow researchers and clinicians unparalleled insight
into the complexities of our genome and diseases. However, the move to these platforms presents new
hurdles in long DNA and RNA sample preparation. Most conventional spin column sample preparation
methods shear DNA during purification, and although agarose plug digestion methods can isolate ultra-long
DNA from samples, the protocols can be difficult, time consuming and highly variable. While newer
technologies have emerged that allow for more rapid extraction of long-DNA, these kits are either limited in use
to easy-to-lyse sample types (cells and blood) or require extra equipment and long processing times, which
significantly increases the cost. At Claremont BioSolutions (CBio), we are developing a novel automated
extraction technology that will incorporate lysis, nucleic acid binding and isolation. The technology will allow
users to add and sample, hit “GO” and in 30 minutes collect DNA or RNA. In Aim 1, we will integrate our fast
lysis and isolation technology into an automated cartridge to provide reproducible high quality, ultra-long DNA
or RNA extraction. In Aim 2, we will validate automated ultra-long DNA extraction using easy and complex
sample types, compare our technology to HMW DNA competitor's kits, and demonstrate improved long-read
sequencing using two third generation technologies. In Aim 3 we will test automated RNA extraction and
downstream native RNA sequencing. In Aim 4 we will perform pre-market analysis at off-site alpha and beta
testing facilities to generate end-user feedback and lockdown the design. The proposed system would simplify
workflow, lower cost, and reduce variability.

Public health relevance
Narrative Claremont BioSolutions, LLC (CBIO) Isolating high quality nucleic acid from samples for downstream third generation sequencing and mapping applications is often difficult, labor intensive and highly variable. This project will automate a new technology to allow rapid isolation of ultra-long DNA and RNA from cells, tissues, and more complex samples types for downstream NGS and long-read genomic applications.